Novel, On-demand VR for Accessible, Practical, and Engaging therapy (NO VAPE)

Project Summary/Abstract
Vaping is an increasing problem in the US, carrying significant health risks. In 2019, 25% of high school students
reported past month vaping. One million adolescents and 1.3 million never-smoking adults are now dependent
on vaped nicotine. Nicotine vaping is associated with multiple adverse reactions including oral health issues,
lung injury, and cardiac, respiratory, and gastrointestinal disorders. Limited vaping cessation interventions have
been developed; and current treatments have limited accessibility due to systemic barriers to care, including
scarcity of treaters, and high cost. Digital therapeutics (DTx) can be used to reduce these barriers; the current
DTx is This Is Quitting (TIQ), a free text messaging application that uses education and behavioral psychology
to support vaping cessation. TIQ is the only intervention with proven efficacy for nicotine vaping cessation to
date. Embedding CBT content into virtual reality (VR) is a strategy Charles River Analytics employed in a
successful NIDA SBIR, Constructed Environments for Successfully Sustaining Abstinence Through Immersive,
On-Demand Treatment (CESSATION), developed in partnership with Drs. Corinne Cather and Eden Evins at
Massachusetts General Hospital. Here, we propose to develop and test an engaging and immersive VR-based
cognitive behavioral therapy (CBT) app focused instead on vaping: Novel, On-demand VR for Accessible,
Practical, and Engaging therapy (NO VAPE). NO VAPE allows users to practice CBT skills gained in traditional
therapy, and provides accessible, immersive, engaging, and ecologically valid practice, motivating greater
intervention adherence and satisfaction, and removing many barriers to care access. Thus, we hypothesize that
NO VAPE will enhance vaping cessation outcomes in chronic vapers who want to quit. In Phase I, we will: (1)
produce 10 VR-based narratives designed to remain novel and engaging across persistent use, (2) solicit
feedback from payors and FDA to ensure positive coverage decisions by payors and meet FDA standards, (3),
conduct Human Factors studies to ensure a low-risk application before Phase II. In Phase II, we will: (4) conduct
a Clinical Trial to test whether NO VAPE is safe and effective so it can augment or change clinical practice, and
(5) prepare to market NO VAPE to potential users. A commercially-available VR-integrated CBT tool for clinicians
and patients will improve clinical practice, and make CBT available to consumers directly if they wish to use it
on their own, helping more people quit vaping.

Public health relevance
Project Narrative No engaging, immersive intervention exists for vaping cessation therapy, and there is no clinical trial to test the efficacy of embedding cognitive behavioral therapy (CBT) content into virtual reality (VR) to increase success at quitting. Here, we propose to expand CESSATION—Charles River’s VR-based CBT-embedded app for smoking cessation—to focus on vaping, producing Novel, On-demand VR for Accessible, Practical, and Engaging therapy (NO VAPE). Current vaping cessation treatments lag far behind treatment for other substance use disorders (SUDs); therefore, a commercially available VR app to be combined with hybrid live and digitized CBT or used alone that increases access, reduces costs, is engaging, realistic, available on-demand, and effective for initiating and maintaining abstinence will help more people quit vaping.